Antibody dependent cellular cytotoxicity and HIV-1 mother to child transmission

PROJECT SUMMARY
Over 150,000 infants acquire HIV-1 from their infected mothers primarily because combination antiretroviral
treatment (cART) remains inaccessible in some populations. Surprisingly even in the absence cART, only
around 20 – 30% of infants get HIV-1 from their mother although they are constantly exposed to the virus
during gestation, birth and breast feeding. Immune factors, such as maternal antibodies, likely prevent
transmission. Mother to child transmission (MTCT) cohorts are an ideal way to examine the impact of pre-
existing antibodies in preventing HIV-1 transmission in a natural setting because: 1) infants are reliably
exposed to the virus; 2) mothers pass their antibodies to the infant; and 3) samples can be obtained from both
the mother and the infant prior to and after transmission. Understanding the role of and the types of antibodies
that can prevent HIV-1 transmission remains one of the highest priorities especially for vaccine efforts. In
contrast to all animal models, MTCT investigations and antibody passive infusion clinical trials demonstrate
that pre-existing neutralizing antibodies (nAbs) do not provide significant protection against HIV-1 transmission.
The major difference among animal models and HIV-1 transmission is that humans are exposed to a diverse
swarm of HIV-1 variants, and some of the strains are neutralization resistant. In setting where the exposed
individual already possesses nAbs, they acquire neutralization resistant variants. In contrast, we show that
infants with pre-existing antibody dependent cellular cytotoxicity (ADCC) against their mother’s neutralization
resistant strains are less likely to acquire HIV-1, and they have lower morbidity up to 1 year after birth in the
absence of cART. We have further observed that transmission depends on both the preexisting ADCC breadth
and potency in the naïve exposed infant and the ADCC sensitivity of the variants circulating in the maternal
variants (exposure strains). We propose to provide more definitive support for the importance of ADCC during
MTCT by exploring if newly infected infants acquire ADCC resistant strains. We will further identify host factors
and virus characteristics that influence ADCC breadth and potency and ADCC susceptibility. We further
hypothesize that ADCC present in infected infants can eliminate cells with infectious virus that can produce
virus. Infants with higher ADCC against their autologous virus have a lower number of residual infected cells. A
smaller number of infected cells results in lower viremia and plasma inflammation, which decreases morbidity
and mortality in the absence of cART. Finally, we will use state of the art techniques to isolate and characterize
broad and potent ADCC antibodies. These studies will provide insights about the characteristics of these
antibodies and the potential novel ways to elicit them using state of the art vaccine methodologies. The
proposed studies will provide clarity about the selection pressure ADCC exerts during transmission, highlight
how pre-existing ADCC decreases mortality, and lead to the generation of novel protective antibodies.
Cumulatively, this work will provide new strategies for developing an effective HIV-1 vaccine.

Public health relevance
PROJECT NARRATIVE Antibody dependent cellular cytotoxicity (ADCC) partially protects exposed infants from acquiring neutralization-resistant HIV-1 from their chronically infected mothers and it decreases infected infant mortality. This proposal will investigate ADCC selection pressure during mother to child transmission and estimate ADCC impact on level of infected cells and inflammation in infected infants. We will identify the ADCC antibodies that influence mother to child transmission and characterize their properties, which may highlight novel avenues for future vaccine strategies.